Continued Implementation and Maintenance of the Manufactured Foods Regulatory Program Standards and Food Protection Task Force by the South Carolina Department of Agriculture

Project Summary/Abstract
The South Carolina Department of Agriculture (SCDA) has achieved full implementation and full
conformance with the ten (10) standards of the Manufactured Foods Regulatory Program
Standards (MFRPS) as noted in the August 8-9, 2022, interval assessment by FDA. These
standards establish requirements for the critical elements of a regulatory program designed to
protect the public from foodborne illness and injury. These elements include the program’s
regulatory foundation, staff training, inspection, quality assurance, food defense preparedness
and response, foodborne illness and incident investigation, enforcement, education and
outreach, resource management, laboratory resources, and program assessment. Each
standard contains a purpose statement, requirement summary, description of program
elements, projected outcomes, and a list of required documentation. With funding from RFA-
FD-23-027, over the next three years, the MFRPS staff will continue to maintain all ten
standards.

Public health relevance
Project Narrative The South Carolina Department of Agriculture (SCDA) has achieved full implementation and full conformance with all standards of the Manufactured Foods Regulatory Program Standards (MFRPS). Through this cooperative agreement, SCDA will continue to use systematic methods to maintain these achievements along with identifying and overcoming obstacles to maintain full conformance with the 2022 standards and ensure the citizens of South Carolina a safe and wholesome food supply. The South Carolina Food Safety Task Force provides food protection program coordination and information-exchange between industry, academia, state and federal regulators, and other state agencies at scheduled quarterly meetings. 1